KOMP2-Phase3 Production and Phenotyping by the DTCC Consortium TCP Transfer to UC Davis

Transfer of KOMP2 Mice and Materials from The Center for Phenogenomics to UC Davis
ABSTRACT
This application from the Knockout Mouse Phenotyping Project (KOMP2) at the University of California, Davis
proposes that UC Davis import mice for 26 lines that have not yet completed production and phenotyping at
TCP. This is being proposed because TCP can no longer participate as a subcontractor on the KOMP2 project
after the start of the next grant period (August 1) in order to be in compliance with the updated NIH Policy on
Foreign Subawards (NOT-OD-25-104) issued May 1, 2026. These 26 mouse lines are novel and unique, and
do not represent any mouse lines that UC Davis has already produced and/or phenotyped. Male and female
mice that have been confirmed for germline transmission of the targeted allele at TCP will be packed and
transferred in 4-5 shipments to UC Davis. Upon arrival, mice will undergo standard importation processing and
confirmation of viability and identity, entered into the KOMP2 project database, raised and bred to produce
adult male and female cohorts in the KOMP2 vivarium space, deposited into the MMRRC at UC Davis as
cryopreserved sperm, and ultimately enrolled in the KOMP2 phenotyping pipeline at UC Davis. This approach
will incur costs for shipping, processing, breeding, genotyping, and cryopreservation. The cryopreserved sperm
will be integrated into the existing MMRRC inventory, making these mouse lines available for distribution to the
biomedical research community, especially NIH funded investigators. The costs to execute this project are
beyond the available support provided by the parent KOMP2 grant to UC Davis. If awarded, funds will be used
to complete this project during the current grant year.

Public health relevance
Transfer of KOMP2 Mice and Materials from The Center for Phenogenomics to UC Davis PROJECT NARRATIVE The KOMP2-Phase3 Production and Phenotyping (KOMP2) project at UC Davis is creating and analyzing null mouse models for 409 human genes with little to no known functional annotation or phenotype. In order to comply with the updated NIH Policy on Foreign Subawards (NOT-OD-25-104) issued May 1, 2025, mice for 26 KOMP2 mouse lines that have achieved germline transmission but not yet completed production at will be transferred to UC Davis in order to preserve and protect the NIH investment in the KOMP2 project to date. At UC Davis, these mice will be used for production to complete breeding to generate N2 or later generation male and female cohorts for enrollment in the KOMP2 phenotyping pipeline at UC Davis. Sperm will be harvested from mature male mice to create a cryoarchive for deposition into the MMRRC at UC Davis. The models and data produced will significantly add to what is currently known about normal gene function in healthy development and the consequences of gene dysfunction that often causes human disease.